TISSUE COMPOSITION W/ ATTENUATED TOTAL REFLECTION INFRARED MICROSPECTROSCOPY

Using a small volume mixer with the "continuous flow" method, the flow speed can be made very high, which accelerates the generation of turbulence in the sample flow and thus promotes efficient mixing. Dr. Denis Rousseau has developed such a mixer for resonance Raman and fluorescence spectroscopies, and we have modified the design for use with the synchrotron infrared beam. The mixer is designed such that two solutions are loaded into syringes and pumped at 2 mm/ms into a small mixing well (100 μm wide x 100 μm deep) etched into a stainless steel block. The mixing well is covered by a 50 μm-thick teflon sheet, which has a 200 μm-diameter hole aligned in the center of the mixing well. The solutions mix in the mixing well and flow through the teflon spacer into the infrared "sandwich" cell. The cell is made of two, rectangular CaF2 windows (12 mm x 25 mm), separated by a mylar Hspacer (100 μm thick). The spacer creates a channel 200 μm wide Hthrough the cell and provides a suitable infrared pathlength. By Hmoving the position of the infrared beam along the length of the infrared cell, different time points in the folding reaction can be probed. Since the dead time of the mixer is ~100 μs, the time resolution of this rapid-mix flow cell is on the order of hundreds of microseconds to a few milliseconds.